Optogenetic engineering of thermogenic adipose tissue as a novel cell therapy for obesity

Obesity and the associated metabolic syndrome represent a profound public health challenge, afflicting over
40% of the United States population and nearly 50% of African Americans and Hispanics. The metabolic
consequences of obesity, include heart disease, diabetes, and cancer, make up the leading causes of
preventable death in the US. Fundamentally, obesity arises in the setting of nutrient excess when dietary
energy intake exceeds energy expenditure from metabolic processes and physical activity. Strategies to
combat obesity are thus directed at either decreasing appetite or increasing energy expenditure. While
significant progress has been achieved with hormonal suppression of food intake, these medications are have
significant side effects, rebound weight gain when discontinued, and are so expensive to manufacture that that
their cost to the US healthcare system would exceed $1 Trillion dollars per year to maintain weight loss for all
eligible patients. GLP1-based therapeutics are highly effective at reducing energy intake through appetite
suppression, however there are currently no approved therapies to increase energy expenditure. This
represents a promising avenue of study, as patients who have achieved significant weight loss have an
adaptive reduction in basal metabolic rate, resulting in weight loss plateau or regain due to decreased energy
expenditure. Exercise is unfortunately ineffective for most patients because it stimulates an increase in food
intake that largely offsets energy expenditure. Therefore, there exists a clear therapeutic need for treatments to
bolster energy expenditure to compliment GLP1-based initial weight loss and enable long-term weight
maintenance. Thermogenic adipose tissue, an evolutionary optimized cellular “furnace” that burns energy in a
safe and controlled manner, represents an ideal target to augment energy expenditure. Unfortunately, obese
patients possess insufficient native thermogenic adipose to effectively improve metabolism, and efforts to
recruit additional thermogenic adipocytes have been plagued by off-target complications. Importantly, the
thermogenic machinery is normally quiescent under basal conditions and does not contribute to energy
expenditure until stimulated by β-adrenergic signaling. Thus, simply creating more thermogenic adipose fails to
activate its full energic potential. This proposal leverages recent breakthroughs from our lab in the discovery of
adipose progenitor subpopulations to enable the ex vivo expansion of thermogenic adipose, as well as
engineering a molecular switch to regulate energy expenditure. Most notably, this work will directly address the
critical requirement for a molecular throttle to control thermogenic adipose stimulation with the innovation of a
novel light-activated receptor. This optogenetic approach will not only contribute to our understanding of the
metabolic and signaling processes evoked by thermogenic activation, but could ultimately serve as the
foundation for the development of first-in-class cell therapeutics to treat obesity.

Public health relevance
Project Narrative Obesity and the metabolic syndrome arise in the setting of chronic energy surplus, and there are no current treatment modalities designed to augment energy expenditure. Thermogenic adipose tissue represents a promising anti-obesity target that consumes energy to produce heat, and is well suited to ex vivo expansion and genetic engineering. This project aims to use peripheral optogenetic stimulation of thermogenic adipose tissue to augment energy expenditure and provide a viable therapeutic option for the lifelong maintenance of weight loss.